Synergistic integration of topology and machine learning for the predictions of protein-ligand binding affinities and mutation impacts

Project Summary Fundamental challenges that hinder the current understanding of biomolecular systems are their tremendous complexity, high dimensionality and excessively large data sets associated with their geometric modeling and simulations. These challenges call for innovative strategies for handling massive biomolecular datasets. Topology, in contrast to geometry, provides a unique tool for dimensionality reduction and data simplification. However, traditional topology typically incurs with excessive reduction in geometric information. Persistent homology is a new branch of topology that is able to bridge traditional topology and geometry, but suffers from neglecting biological information. Built upon PI’s recent work in the topological data analysis of biomolecules, this project will explore how to integrate topological data analysis and machine learning to significantly improve the current state-of-the-art predictions of protein-ligand binding and mutation impact established in the PI’s preliminary studies. These improvements will be achieved through developing physics-embedded topological methodologies and advanced deep learning architectures for tackling heterogeneous biomolecular data sets arising from a variety of physical and biological considerations. Finally, the PI will establish robust databases and online servers for the proposed predictions.

Public health relevance
Project Narrative The project concerns the integration of topological data analysis and machine learning architectures for the predictions of protein-ligand binding affinities and mutation induced protein stability changes from massive data sets. This new data approach has considerable impact for future generation methods in computational biophysics and drug design.